Identifying breath biomarkers for S. aureus methicillin resistance and small colony variants

PROJECT ABSTRACT: A primary cause of death for most persons with cystic fibrosis (CF) is respiratory
failure caused by damaging chronic lung infections and inflammation. Staphylococcus aureus is the most
common cause of lung infections in the US CF population, with 70% of patients testing positive for S. aureus
in 2018. There are two subtypes of S. aureus that are particularly worrying because they are linked to lower
lung function and higher risk of death: methicillin-resistant S. aureus (or MRSA) and small colony variants (or
SCVs). Approximately 50% of CF patients test positive for MRSA and 28% test positive for SCVs. Testing for
S. aureus, MRSA, and SCVs heavily relies upon the collection of sputum, but as CF care improves and use
of CFTR modulators increases, the production of sputum is declining, though the risk of lung infections
persists. Therefore, novel methods for diagnosing lung infections without sputum are urgently needed.
Our long-term goal is to develop a breath test for the detection of S. aureus MRSA and SCV in chronic CF
lung infections. The overall objective of this proposal is to identify putative breath biomarkers of MRSA and
SCVs and to determine their diagnostic accuracy. Our central hypothesis is that volatile biomarkers in breath
can be used to rapidly and sensitively detect MRSA and SCVs, independent of co-infections with other
species, or the presence of other S. aureus isolates. We will test our hypothesis by leveraging well-
characterized S. aureus isolates from the Small Colony Variant S. aureus (SCVSA) study (Aim 1), and paired
sputum and breath specimens from the IMproving P. Aeruginosa deteCTion using Breath (IMPACT-Breath)
study (Aim 2). The expected outcomes of this project are breath biomarkers of S. aureus MRSA and SCVs,
and estimates of their sensitivity and specificity in the breath of persons with CF.
Aim 1: Identify putative volatile biomarkers of MRSA, SCVs, and MRSA-SCVs grown in vitro. We will
characterize the volatile metabolomes of methicillin sensitive-normal colony variant (MSSA-NCV), MRSA-
NCV, MSSA-SCV, and MRSA-SCV isolates cultured in vitro, utilizing 100 sequenced and phenotyped isolates
from the SCVSA study. We hypothesize that there are distinct volatile biomarkers for MRSA vs. MSSA and
for SCV vs. NCV isolates, and that a novel set of biomarkers are produced by MRSA-SCV isolates.
Aim 2: Refine putative volatile biomarkers of MRSA and SCV and estimate their accuracy in the breath
of persons with CF. We will analyze paired sputum and breath samples from 100 S. aureus positive CF lung
infections from the IMPACT-Breath study. We will use culture-dependent and culture-independent methods
to identify and quantify MRSA and SCVs in the sputum and correlate these data to each subject’s breath
volatiles. We hypothesize that volatile biomarkers for MRSA and SCV will be detected in the breath of persons
that are culture-positive for these S. aureus subtypes, even in the presence of other microbial species, and in
the presence of MSSA and NCVs.

Public health relevance
Project Narrative Recent scientific evidence indicates that Staphylococcus aureus small colony variants are contributing to lung function decline and other poor outcomes in persons with cystic fibrosis (CF) lung infections. The standard-of- care for detecting lung pathogens in CF is by culturing sputum, but new CF therapies make it more difficult for patients to produce sputum, although their risk of lung infection is still high. The aim of this project is to identify breath biomarkers of S. aureus small colony variants and methicillin resistance (MRSA) that would enable the non-invasive and rapid detection of these infections in patients that can’t produce sputum.